Core C - Bioanalytical Resource Core

Project Summary
The Bioanalytical Core (Core C) serves the O'Brien Center community, both at UAB and UCSD and the
Extended Research bBase by providing state-of-the-art bioenergetics, oxidative stress analysis, and metabolite
and biomarker analysis support for acute kidney injury (AKI) research. Core C provides a comprehensive
resource that includes optimized protocols and technology for bioanalytical analyses of oxidative stress and
cellular bioenergetics, biomarkers of AKI, post-translational modifications, and changes in small molecule
biochemistry. The services involve consultation, training in experimental design, recovery of samples suitable
for analysis and assay performance. Services offered include unique techniques to determine mitochondrial
bioenergetics, LC-mass spectrometry based assays for creatinine, F2-isoprostanes and citric acid cyle
intermediates. New services being offered through Core C include imaging mass spectrometry for kidney
tissues, state-of-the-art nanoLC-MS methods for both targeted and untargeted metabolomics in clinical
samples and from animal models of AKI.
The Bioanalytical Core has continued to provide a unique portfolio of services for the investigator base
of the O'Brien Center. Since 2013, Core C has performed more than 53,000 services/assays for 187
investigators involving 226 projects. Of the 187 core users, 155 were non-core investigators. Core C also
provided support for 17 pilot and feasibility and catalyst grant awardees. These combined efforts have been
recognized in 86 peer-reviewed publications. Productivity benchmarks for Core C demonstrate an increase of
>300% for investigators (especially non-core investigators), supported projects as well as publications
compared to the prior funding cycle. The Core participates in education and training of investigators providing
hands-on experience and scientific interchange. A recurring feature is an annual 4.5-day workshop for training
in metabolomics. The Bioanalytical Core, in concert with the O'Brien Center leadership, provides a strong
catalyst to support investigators to advance kidney-related research.